The Adolescent Surgery Experience: Preoperative Anticipatory Guidance and Postoperative Opioid Misuse (POM)

PROJECT SUMMARY
Each year, over 1.4 million US adolescents undergo surgery. Between 3-5% of opioid-naïve adolescents
continue to fill opioid prescriptions 3-6 months after surgery, which is long after acute surgical pain has resolved
and may signify a new opioid use disorder. Due to complex biopsychosocial changes, there is significant concern
among experts that adolescents may be at increased risk of perioperative opioid-related adverse outcomes,
including postoperative opioid misuse (POM), defined as use after severe surgical pain resolves (>14 days after
surgery), opioid use disorder and overdose. Anticipatory guidance is endorsed by the American Academy of
Pediatrics for risk prevention among adolescents. It is routinely utilized in outpatient pediatric settings to prevent
high-risk behaviors, including those related to opioid and substance use. However, anticipatory guidance, with
its educational and behavioral components, has not been studied in the perioperative setting. To gather
preliminary data, the principal investigator, Dr. Sutherland, completed an observational study of 501 adolescents
with six months of follow-up at the Children’s Hospital of Philadelphia (CHOP). Among patients undergoing
reconstructive knee surgery (ligament repair), 8% used any opioids in Week 2 after surgery, but 44% endorsed
opioid use (median 5 days) in Weeks 3 and 4, consistent with unintended opioid misuse; interviews suggest use
was associated with anxiety and uncertainty over recovery. The central objective for this proposal is to improve
knowledge of effective anticipatory guidance techniques and design an intervention to prevent POM that is both
adolescent-centered and reflective of perioperative considerations that will be evaluated in a subsequent R01-
funded trial. This proposal includes: (1) a retrospective cohort study to establish contemporary (pandemic-era)
dispensing trends and determine the association between patient characteristics and adverse opioid-related
outcomes, (2) semi-structured interviews with surgeons, who vary in opioid dispensing practices, and
adolescent-caregiver dyads to characterize effective surgical anticipatory guidance and POM themes to inform
an adolescent-centered intervention, and (3) a single-arm feasibility study to measure acceptability of an
anticipatory guidance intervention to prevent POM. With this proposal, Dr. Sutherland’s overarching career goal
is to develop as a clinical trialist focused on prevention trials. To accomplish this, she seeks to gain additional
training in the following domains: (1) use of population data to inform trial design (2) qualitative methodology to
inform intervention design and (3) foundation in clinical trial design and conduct. Dr. Sutherland will conduct the
proposed research at the Children’s Hospital of Philadelphia within the University of Pennsylvania and is
supported by mentors, advisors and consultants with significant experience in trial design, specifically pragmatic
and prevention trials, advanced biostatistical analysis, application of qualitative data to intervention design,
adolescent psychology and addiction medicine.

Public health relevance
PROJECT NARRATIVE Millions of previously opioid-naïve adolescents will have their first opioid exposure in the perioperative setting and are at elevated risk of opioid-related adverse outcomes, including misuse and opioid use disorder, especially with increased duration of opioid exposure and use for non-severe surgical pain or non-surgical symptoms. This career development award application proposes to adapt anticipatory guidance, a well- respected practice in outpatient pediatrics, to the perioperative space to equip and empower adolescents with the knowledge to avoid high-risk opioid use after surgery. Using an established intervention framework adapted to the perioperative environment, the Principal Investigator will develop a contemporary, adolescent-centered anticipatory guidance intervention to prevent postoperative opioid misuse (>14 days) among adolescents undergoing reconstructive knee surgery.